Research Software Engineering Support For The Simvascular Open-Source Project

Patient specific simulations of blood flow and tissue biomechanics have become a crucial
component of fundamental research in treatment planning, medical device design, and
mechanisms of disease progression in cardiovascular (CV) disease. SimVascular is the only fully
open-source software package providing state-of-the-art image-based blood flow modeling and
analysis capability to the CV biomechanics community. Over the past several years, our team
established SimVascular as a vibrant open-source project, attracting over 10,000 new users
worldwide, and facilitating high-impact research and >1000 publications. Recent advances in
SimVascular include the addition of new multi-physics solver capabilities for large deformation
fluid structure interaction (FSI), electrophysiology and cardiac mechanics, reduced order models,
and machine learning (ML) methods for image segmentation. The proposed project would support
Dr. David Parker, a research software engineer (RSE) in the Marsden lab at Stanford who leads
software development for SimVascular. During the three-year funding period, Dr. Parker will make
essential contributions to 1) code improvements, development, and integration of new features,
2) improved architecture for sustainability and modularity, and 3) dissemination and user
community support. Dr. Parker is supporting three R01-funded projects (Marsden PI) which all
rely on SimVascular as an essential software resource. These high-impact projects span adult to
pediatric cardiovascular disease and will produce new computational methods for fluid solid
growth simulations, digital twins of pulmonary hemodynamics, and multiphysics cardiac
simulations for surgical planning. Importantly, in support of this NIH funded research, Dr. Parker
will ensure that software developed by trainees is hardened (e.g. standard data structures),
integrated, tested (e.g. GitHub actions), documented (e.g. Doxygen) and publicly released as part
of SimVascular (e.g. code reviews before merging). Without Dr. Parker serving in this essential
role, it would be extremely difficult to make these advancements publicly available to the research
community while adhering to best software practices and ensuring usability. Bringing experience
from the software engineering industry, Dr. Parker is instrumental in supporting trainees by
teaching software standards, agile development, good coding practices, debugging methods, and
testing strategies. Dr. Parker intends to remain a career RSE dedicated to the SimVascular
community. He intends to apply for follow up funding from private foundations. Career goals
include growth of the SimVascular user community, increased use by medical device startup
companies, and deployment in a clinical service at Lucile Packard Children’s Hospital at Stanford.

Public health relevance
SimVascular is a vibrant and growing open-source software project for modeling blood ﬂow and biomechanics in the heart and circulatory system. This project would provide support for Dr. David Parker, a career research software engineer to support software development, sustainability, and dissemination to support NIH funded projects and the wider SimVascular user community.